Mechanism of LSD1 in breast cancer metastasis suppression

Comparisons of genetic mutations found in primary tumors and their corresponding metastatic lesions have
so far failed to define genetic mutations that lead to metastasis. This raises a notion that it is the epigenetic
mechanisms, working together with cancer type-specific oncogenic and/or cell type-specific lineage programs,
that may drive metastatic progression. In breast cancer, how epigenetic abnormalities drive metastatic
progression remains largely elusive. A better understanding of this may lead to novel strategies to block
breast cancer metastasis. LSD1 (KDM1A) is the first identified histone demethylase. In human cancers,
genetic abnormalities of LSD1 mainly include deletions and mutations. Such deletions/mutations have also
been found in metastatic breast cancer, raising a possibility that LSD1 is a breast cancer metastasis
suppressor. Indeed, in preliminary studies, we found induced loss of LSD1 in luminal mammary tumor cells
or LSD1 inhibitor treatment in the MMTV-PyMT mouse model led to a dramatic increase in lung metastasis.
Mechanistically, in luminal breast cells, we found LSD1 interacts with GATA3, a key luminal-specific
transcription factor, to control their common programs related to cell-cell adhesion and cell cycle. LSD1
positively regulates GATA3 expression and represses that of TRIM37, a common target of both LSD1 and
GATA3, which encodes a histone H2A ubiquitin ligase involved in gene repression. Importantly, TRIM37 may
contribute to increased invasion and migration of luminal breast cancer cells with LSD1-loss via repression of
several cell adhesion genes (e.g., CDH1, VCL, CTNNA1). Such expression changes were also observed in
murine PyMT tumor cells with LSD1-loss. Together, these data suggest that LSD1 may suppress breast
cancer metastasis via regulation of its target genes (e.g., TRIM37) in luminal cells in a demethylase activity-
dependent manner. Intriguingly, PyMT tumor cells with LSD1 ablation also exhibited a profound change in
immune-related genes, suggesting that LSD1 may also suppress breast cancer metastasis by a cell-extrinsic,
immune-related mechanism. To test these, we will continue to establish mouse intraductal injection (MIND)
transplantation models for PyMT tumor cells and human estrogen receptor+ breast cancer cell lines as our in
vivo system. In Aim 1, we will perform CRISPR-based screens to map functional domain(s) of LSD1
responsible for its metastasis suppression vs. proliferation/survival-supporting roles, and test if LSD1
mutations found in patients impair its metastasis suppression function via disruption of the demethylase
activity. In Aim 2, we will determine roles of LSD1 targets (e.g., TRIM37 and its partner EZH2, and others) of
luminal cells at different steps of the metastatic cascade in various MIND models. In Aim 3, we will determine
the immune mechanism mediating increased PyMT metastasis associated with LSD1 ablation, in particular,
NK cells and MHC-I molecules, as LSD1-loss in PyMT tumor cells led to a profound upregulation of various
classic and non-classic MHC-Is, which serve as ligands for inhibitory receptors in NK cells.

Public health relevance
As gene mutations found in cancers that spread to other organs (i.e., metastasis) are not too much different from those found in primary tumors from the same patients, scientists have proposed that non-genetic heritable mechanisms referred to as epigenetic mechanisms may be the “real” driver for metastasis. The purpose of this project is to study how loss of LSD1, an epigenetic regulator, contributes to increased breast cancer metastasis, by both cell-intrinsic (i.e., via its regulation of key target genes in breast epithelial cells) and extrinsic (e.g., immune cell-related) mechanisms. The knowledge from this project may translate into novel therapeutic targets and strategies to treat and/or prevent the metastatic disease.